Intraoperative Identification of Cranial Nerves in Skull Base Surgery Using Polarization Sensitive Optical Coherence Tomography

Project summary/abstract
Identification of cranial nerves during skull base surgery is critical to avoid iatrogenic injury. Even the
slightest damage to any one of these nerves can hugely affect patient outcomes. Despite the importance
of cranial nerve identification, preoperative imaging struggles to provide the needed information. During
the surgical procedure, electrostimulation techniques are often utilized to provide a point-based analysis
of a nerve and its functional capability, but they remain unable to picture the whole field. In fact, there is
no current clinical tool capable of mapping nerve fibers and displaying their location back to the surgeon
in real time. In this project, we propose to develop an imaging tool that can fill this obvious gap in current
technology and place it directly into the hands of skull base surgeons. This tool will be based on polarization
sensitive optical coherence tomography (OCT), an optical imaging modality that shows exquisite contrast
for myelinated nerves. Recent advances in laser technology (known as circular ranging, invented by
Mentor Dr. Vakoc) have brought OCT lasers to a point where their use is compatible with the motion
induced by standard surgical workflow. This two-aim project seeks to bring circular ranging into the
operating theater during skull base surgery and assess its capability to enhance cranial nerve visualization,
uniquely combining both surgical and technical expertise. This work will take place between two NIH-
funded P41-holding institutions: the Wellman Center for Photomedicine at Massachusetts General Hospital
(MGH), home to the Center for Biomedical OCT Research (CBORT), and Brigham and Women’s Hospital
(BWH), home of the National Center for Image-Guided Therapy (NCIGT) where the resources of the
Advanced Multi-modality Image Guided Operating suite (AMIGO), both in terms of equipment and
experience, will provide the perfect environment to conduct such a study. The candidate for this award is
Dr. Danielle J. Harper, a postdoctoral fellow at MGH and Harvard Medical School. Dr. Harper has been
well trained in the field of biophotonics. Her area of expertise is OCT and its functional extensions, including
polarization mapping and depth-resolved spectroscopy. Her long-term career goal is to reach academic
independence and lead a research group focused on intraoperative optical neuroimaging. To help her
achieve this, Dr. Harper has built a strong team to guide her in all aspects of research and career
development. Dr. Benjamin J. Vakoc at MGH/HMS, an expert in optical imaging, will serve as the primary
mentor. Neurosurgeons Dr. Alexandra J. Golby and Dr. Michael Mooney at BWH will provide mentoring,
guidance, and assistance with all clinical aspects. Dr. Lei Tian of Boston University will provide supervision
and guidance for the deep learning aspects of the project, and Dr. Tayyaba Hasan at MGH/HMS will
provide general career development advice. Supported by this team, this career development award will
give Dr. Harper the remaining skills and training she requires to make the transition to full independence.

Public health relevance
Project narrative Nerve damage during neurosurgery is often caused by the challenge of differentiating nerves from their surrounding tissues. This project seeks to design, construct, and implement a new tool that can visualize nerves across the whole surgical field and place it directly into the hands of skull-base surgeons. In the long term, a tool such as this could result in a decrease in nerve injury rates and a reduction of the related morbidities.